RESEARCH METHODS CORE

The Research and Methods Core (RMC) for the Center for SOcial CApital (SoCa) will be critical for meeting the
Center’s overall mission to reduce cancer health inequities in persistent poverty areas (PPAs) in the New York
City (NYC) Region. The RMC will leverage the exceptional research expertise, training resources, and
infrastructure of Cornell University (CU), Columbia University Irving Medical Center (CUIMC), Downstate Health
Sciences University (Downstate), and the regional healthcare systems and networks of New York-Presbyterian
(NYP) Hospital System and the NYC Department of Health’s Center for Health Equity, Cancer Prevention and
Control, and Department of Education to conduct prevention, screening, treatment, and disease management
interventions to alleviate cancer health inequities related to persistent poverty.
The RMC will support and coordinate the research enterprise within the SoCa Center and facilitate data
synergy in the Persistent Poverty Steering Committee. By bringing together a diverse cadre of PhD and clinician
scientists in biostatistics, epidemiology, social determinants of health, cultural humility, data harmonization,
implementation science, and patient-reported outcomes, the RMC will support the Center’s transdisciplinary
research teams, foster data synergy and integration of the research projects and pilot projects, support planning
and evaluation of the Center’s research productivity, and facilitate data connections with the Persistent Poverty
Initiative Network. The RMC will provide research methodology support for Project investigators, trainees and all
pilot projects focused on reducing cancer inequities in areas of persistent poverty.
The RMC will support the Center’s mission through the following aims: (1) Provide rigorous study
design, methodologic expertise, biostatistics consultation, and data interpretation support to both projects and
all pilot studies through the developmental core; (2) Build a Data Commons platform to ensure data
harmonization and facilitate connections across the SoCa Center, the NYC region and through the larger
Persistent Poverty Initiative Network. Standardize data collection, storage, and incorporating data elements,
surveys, and measures across projects and pilot studies to build data synergy across the network; and (3)
Monitor the SoCa Center’s research productivity and dissemination of findings and approaches using
standardized metrics (e.g., number of consultations per month, support for trainees and faculty) and
implementation science frameworks (e.g., The Consolidated Framework for Implementation Research (CFIR))
and provide formal feedback (e.g., user satisfaction, methodology needs assessments) to the ADMIN,
Development Core, and Career Enhancement Core to inform long-term sustainability. The RMC will support
the mission of the SoCa Center by maintaining and facilitating the conduct of high-quality science, ensuring
data harmonization across all projects and pilots, sustaining rigorous standards of research, and promoting
long-term sustainability and dissemination of novel and effective approaches.